Supplement for Cloud Computing: Opioid Policy Models

PROJECT SUMMARY/ABSTRACT
In our study, Opioid Policy Modeling in North Carolina (5R01DA04799), we developed an agent-based
simulation model (ABM) to inform policy makers and health professionals in North Carolina about local and
state-wide interventions to reduce opioid overdoses and related deaths. Interventions are identified in the NC
Opioid Action Plan and cover the Three Pillars: prevention, connection to care, and harm reduction.
Our ABM represents a community (e.g., a county, town) of networked individuals (e.g., patients, physicians,
dealers), and simulates how proposed interventions affect individual pathways to opioid misuse and other
outcomes (i.e., OD death). The model relies on a synthetic population representing every individual in the
United States, which allows information from multiple datasets to be probabilistically connected in one
model. Synthetic individuals are positioned in geospatial context that includes the locations of hospitals,
other treatment facilities, and service providers.
Cloud infrastructure will allow us to speed up realistic simulations and consider more scenario options than
are considered on a current “in-house” computational infrastructure. It will enable us to develop a meta-
model summarizing a multitude of scenarios. Benefits of cloud computing will affect geospatial calibration,
validation, and scenario simulations.

Public health relevance
PROJECT NARRATIVE In our study, Opioid Policy Modeling in North Carolina (5R01DA04799), we developed a complex geospatial agent-based simulation model (ABM) to inform policy makers and health professionals in North Carolina about local and state-wide interventions (e.g., prevention, connection to care, and harm reduction) to reduce opioid overdoses and related deaths. Cloud infrastructure will allow us to speed up realistic simulations and consider more scenario options than are considered on a current “in-house” computational infrastructure. It will enable us to develop a meta-model summarizing a multitude of scenarios Benefits of cloud computing will affect improve geospatial calibration, validation, and scenario simulations.